SANDIMMUNE IN STABLE RENAL TRANSPLANT PATIENTS WHO ABSORB CYCLOSPORINE POORLY

This study is being performed to determine if Sandimmune oral solution and Sandimmune soft gelatin capsules are bioequivalent in stable renal transplant recipients who absorb cyclosporine poorly.